Gene regulatory mechanisms driving development during transcriptional silence from oocyte to embryo in mammals

PROJECT SUMMARY/ABSTRACT
The transition from a fully differentiated oocyte to a totipotent embryo is one of the most dynamic
transitions in biology. Remarkably, this transition occurs in the absence of new transcription. In
the mouse, transcription is globally silenced in the oocyte before ovulation and is not fully
reactivated until the late 2 cell embryo stage. This period of transcriptional quiescence is highly
conserved from worms to humans, and oocytes that fail to undergo transcriptional silencing are
not fully competent to support further development. Without new transcription, the oocyte and
early embryo depend upon post-transcriptional mechanisms to regulate gene expression to drive
development through this window of transcriptional silence. However, the mechanisms required
to silence transcription in the oocyte and orchestrate gene expression in the absence of
transcription during development remain poorly understood, particularly in mammals. A better
understanding of these mechanisms is critical both to improve our understanding of the earliest
stages of mammalian development and the diagnosis and treatment of infertility, as only ~50% of
in vitro fertilized human embryos successfully traverse this period of transcriptional silence.
The overarching goal of this project is to uncover molecular mechanisms required for successful
developmental progression from oocyte to embryo during this window of transcriptional silence.
One post-transcriptional mechanism known to play a critical role during this period is regulation
of mRNA polyadenosine (poly(A)) tail length in the cytoplasm to control translation, where
cytoplasmic polyadenylation activates translation and deadenylation leads to translational
repression and/or decay. In recent findings from our laboratory, we have profiled poly(A) tail
lengths transcriptome-wide across the entire transition from oocyte to embryo. Integrating these
data with recently published ribosome profiling data, we have produced the first transcriptome-
wide analysis of poly(A) tail and translation dynamics across the entire oocyte-to-embryo
transition in a mammalian system. Building on these data, we plan to use the mouse model to
investigate (i) the mechanisms that drive global transcriptional silencing in the oocyte; (ii) the post-
transcriptional mechanisms regulating poly(A) tail length and gene expression during
transcriptional silence; and (iii) regulation of maternal factors required to mediate reprogramming
to totipotency.
These studies will advance our understanding of the mechanisms that drive gene
expression and development during transcriptional silence from oocyte to embryo in
mammals, with the long-term potential to improve the diagnosis and treatment of infertility.

Public health relevance
NARRATIVE The transition from a fully grown oocyte to an embryo capable of driving development of an entirely new organism is one of the most dynamic transitions in all of biology but remains poorly understood, particularly in mammals. However, a better understanding is critical as many embryos in the IVF clinic fail to successfully navigate this transition, representing a major barrier to infertility treatment. Using the mouse as a model, the objective of this proposal is to uncover molecular mechanisms required for successful development during the window of transcriptional quiescence that occurs during the oocyte-to-embryo transition with the long-term goal of advancing the diagnosis and treatment of infertility.